Diversity Supplement: Investigating Epithelial Mesenchymal Plasticity in Crainbow mice

Abstract
Please see Abstract included in Research Plan document.

Public health relevance
PROJECT NARRATIVE Intratumor heterogeneity is a driver of breast cancer progression and treatment resistance. The objective of the parent award NCI-1R01CA255372 is to recapitulate the genetic heterogeneity of HER2 oncogenes in a genetically tractable model more closely resembling the human condition. The current supplement proposal seeks to fund a diversity candidate MD/PhD student. This student will focus on epithelial plasticity changes in a HER2 Cancer rainbow mouse model.